Epigenomics of Neurocognitive Function in Breast Cancer

Neurocognitive changes with breast cancer and its treatment are significant symptoms in the majority of
women with this disease. Unfortunately, very little is known about the mechanisms that underlie these
neurocognitive changes, which in turn limits the development of effective treatments and prevention strategies.
Evidence supports that DNA methylation impacts cognitive function (CF) and brain health (BH), exercise
impacts DNA methylation, and exercise impacts CF and BH. Although investigating DNA methylation patterns
has potential to uncover novel biological underpinnings to help us understand neurocognitive changes within
the context of breast cancer and its treatment, no DNA methylation study has evaluated the interrelationships
among CF, BH and exercise within the context of breast cancer and its treatment. The purpose of the
proposed study is to examine the dynamic DNA methylome to identify genes and biological pathways that are
involved with CF and BH within the context of breast cancer and its treatment. This project capitalizes on data
and samples generated through an ongoing project that involves women newly diagnosed with early stage
breast cancer who will receive aromatase inhibitor (AI) therapy and randomizes them to an exercise
intervention or usual care. Because breast cancer and AI therapy impact CF and BH in a negative manner and
exercise impacts CF and BH in a positive manner; this project offers an exemplar, unique opportunity to
identify biological mechanisms involved in CF and BH within the context of breast cancer and its treatment.
Phenotype data for CF will focus on cognitive domains that deteriorate with AI therapy including attention,
working memory, and executive function, and brain health will be measured using neuroimaging including
regional gray matter volume, white matter architecture, and functional dynamics of the brain. Cognitive function
may be mediated by commonly occurring symptoms therefore this study will include evaluating fatigue, sleep
problems, depression, and anxiety for their potential to mediate or moderate the impact of DNA methylation on
CF and BH. Whole genome DNA methylation data will be generated for all women at two time points: at
enrollment when all women will be pre AI therapy and not yet randomized and post 6 months intervention for
those randomized to the exercise intervention and usual care. This allows us to address mechanisms for CF
and BH within the context of breast cancer prior to therapy, within the context of AI therapy, and within the
context of an exercise intervention. An additional aim of this project will replicate significant findings using data
and DNA samples from a project that recruits older healthy individuals, randomizes them to an identical
exercise intervention, similarly measures CF and BH phenotypes, and collects biological samples at the same
time points. Findings from this project have the potential to inform evidence based, mechanistically driven
therapeutic interventions to mitigate the negative consequences of cancer and its treatment.

Public health relevance
Neurocognitive changes with breast cancer and its treatment are significant symptoms in the majority of women with this disease. Unfortunately, very little is known about the mechanisms that underlie these neurocognitive changes, which in turn limits the development of effective treatments and prevention strategies. This project will examine the DNA methylome to identify genes and biological pathways that are involved with neurocognitive function within the context of breast cancer and its treatment providing evidence to inform mechanistically driven therapeutic interventions to mitigate the negative consequences of cancer and its treatment.